Aging Mitochondrial Fragmentation and Metabolic Inflexibility

Summary/Abstract – No Changes from Parent Award
Metabolic flexibility refers to the ability to switch between carbohydrate (CHO) and fat oxidation in
response to changing physiological conditions. A mixed-model design is proposed to interrogate the
hypothesis that the loss of metabolic flexibility in aging is of mitochondrial origin. The design calls for studies on
intact humans, human skeletal muscle (SM) and white adipose tissue (WAT) as well as on rat and mouse SM
and WAT. A segment of the effort on cells and organelles isolated from young and old lab rodents will be
necessary to perform extensive respiratory control studies as well as studies of mitochondrial dynamics and
composition, whereas because of sample size limitations, studies an human mitochondrial preparations will
be involve selective analyses. To test the main hypothesis four cohortsof humans will be studied: sedentary (<
2 hr vigorous PA/wk) and physically active (>5 hr PA/wk) young healthy controls (21-35 yr), older sedentary
and physically active individuals (60-80 yr) of age. Tissues will be harvested from analogous rat populations, 3-
4-month (mo) and 21-23 mo old male and female F344 rats and young (2-3 mo) and old (15 mo) GPR81 null
mice (Aim 4).

Public health relevance
Project Narrative – No Changes from Parent Award A mixed-model design is proposed to interrogate the hypothesis that the loss of metabolic flexibility in aging is of mitochondrial origin. The design calls for studies on intact humans, human skeletal muscle (SM) and white adipose tissue (WAT) as well as on rat and mouse SM and WAT. A segment of the effort on cells and organelles isolated from young and old lab rodents will be necessary to perform extensive respiratory control studies as well as studies of mitochondrial dynamics and composition, whereas because of sample size limitations, studies an human mitochondrial preparations willbe involve selective analyses.